Supplement to Immunological Niches and Noninvasive Biosensors for Autoimmune Monitoring

Multiple sclerosis (MS) is a demyelinating autoimmune disease that is difficult to manage clinically, because
it is characterized by unpredictable periods of remission and relapse. If the disease could be adequately
monitored, it is possible drugs could intervene to prevent damage, reducing rates of relapse and overall
progression. Ideally, it would be possible to repeatedly biopsy the CNS for monitoring, but this is too
challenging/morbid to have utility. In the K99 phase of my work, we developed an approach that harnesses tissue
engineering principles to develop an immunological niche (IN) in vivo to enable harvest of physiologically relevant
immune populations. Furthermore, we developed synthetic biology-based biosensors that produce optically
detectable signals in response to specific ligands. In the R00 phase, I propose to continue my work in this space,
by testing the biosensors in vivo, engineering INs that specifically enrich pathogenic populations of adaptive
immune cells, and leverage the combination biosensors and engineered IN to monitor expression of cytokines
during antigen presentation in vivo. In Aim 2 (in progress) we developed three different engineered receptor
systems that upon binding ligand dimerize and liberate an engineered transcription factor (TF). This TF traffics
to the nucleus and induces expression of a transgene (bioluminescent protein). In the remaining work for Aim 2,
we will load these cells into biomaterial niches and implant them in vivo to monitor for expression of specific
cytokines involved in experimental autoimmune encephalomyelitis (EAE – mouse model of MS). In Aim 3 we
will develop INs reflective of adaptive immune populations in the CNS, by incorporating antigens within the
scaffolds. This section will create a non-invasive sensor and multivariate signature reflective of adaptive immune
changes within the surrogates and harness both innate and adaptive INs to investigate mechanistic questions
about innate-adaptive crosstalk in the development of MS. Taken together these studies will create engineered
immunological niches and non-invasive sensors that enable the creation of enhanced diagnostics, prognostics,
treatment monitors, and longitudinal immunology studies without euthanasia.

Public health relevance
Project Narrative Multiple sclerosis is an autoimmune disease characterized by immune infiltrate into the CNS and subsequent damage to myelin, that is difficult to diagnose and monitor because the site for disease cannot be readily biopsied for analysis. The goal of this proposal is to create engineered immunological niches and corresponding non- invasive sensors that will correlate with the innate or adaptive immune responses during disease onset and progression by implanting engineered scaffolds in the subcutaneous space. The implications of this work are broad including diagnostics, prognostics, treatment monitoring tools, and research tools to enable longitudinal isolation of disease-inducing cells or non-invasive protein measurements from a single host without euthanasia.